Targeted Neuroplasticity via vagus nerve stimulation to improve urinary dysfunction after spinal cord injury

Project summary: Restoration of urinary dysfunction is often in the top 25% priority for rehabilitation in
individuals after spinal cord injury (SCI), often ranking higher than restoration of upper limb function. However,
current treatments are mostly limited to conservative approaches consisting of intermittent catheterization and
behavioral changes such as fluid intake management, but these interventions only provide symptomatic relief
and are associated with recurrent urinary tract infections, kidney disease, and high mortality rates. While other
pharmaceutical and surgical treatments may be available for some patients with specific complaints such as
overactive bladder, the development of novel therapies to improve and restore bladder function after SCI is of
clear importance.
Vagus nerve stimulation (VNS) paired with rehabilitation is a neuromodulation technology that has demonstrated
great potential at restoring motor and sensory function after neurological injury, including incomplete SCI. VNS
promotes neuroplastic changes by the timed-release of neuromodulators that can enhance recovery. Here we
propose for the first time, a strategy of pairing VNS with bladder function after incomplete SCI to improve
symptoms of urinary dysfunction. Our preliminary results support the use of this technology to restore bladder
function after SCI.
We propose to conduct clinical and preclinical research concurrently to accelerate technology translation. Aim 1
(K99 phase) leverages a separate, ongoing clinical trial (NCT04288245) that has 15 participants, who have the
VNS system already implanted and willing to partake in novel therapy approaches. This aim, will demonstrate
that VNS therapy paired with bladder function can improve voiding efficiency in humans after SCI. To achieve
this, we will modify the interface of the VNS system (ReStore VNS system; FDA-cleared for upper limb
rehabilitation after stroke and currently undergoing phase 2 clinical trials for upper limb rehabilitation after SCI)
to allow pairing with volitional bladder voiding and conduct a pilot study in currently implanted individuals. Aim 2
optimizes the timing of delivery VNS paired with different stages of the bladder function to improve voiding
efficiency in the rat model (sub-Aim 2.1, K99/R00 phase) and characterizes the mechanisms of action behind
those changes (sub-Aim 2.2, R00 phase).
During Dr. Hernandez-Reynoso’s career, she has extensively investigated the use of electrical stimulation
targeted to the peripheral nervous system as a novel treatment of urinary dysfunction, and the development of
peripheral and central neural interfaces. As such, she is the ideal candidate to carry this proposal to completion.
Results from both aims of this proposal will support the submission of an R01 to conduct an independent clinical
trial, and act as a catalyst for the candidate to reach independence as a translational researcher in the neural
engineering and bioelectronic medicines field.

Public health relevance
Restoration of bladder function after spinal cord injury ranks as one of the highest priorities of affected individuals, but novel therapies been insufficiently investigated. After incomplete spinal cord injury, vagus nerve stimulation paired with rehabilitation therapy has been shown to strengthen the neural control of spared pathways, restoring motor and sensory function. In this study, we investigate for the first time, the use of vagus nerve stimulation paired with bladder function to improve the symptoms of urinary dysfunction after spinal cord injury.